Innate immune regulation of lung inflammation through mitochondrial dynamics

PROJECT SUMMARY
In the US alone, asthma affects approximately 24 million individuals, 6 million of whom are children under the
age of 18, and is responsible for over 3,000 deaths annually1,2. A population of immune cells, called group 2
innate lymphoid cells (ILC2s), are integral in driving lung inflammatory diseases including asthma through
production of type 2 cytokines in response to tissue `alarmin' cytokine signals. Despite these advances on ILC2
function, there is a fundamental gap in our knowledge of the intracellular pathways that control this pathologic
capacity within pro-inflammatory ILC2s. In new preliminary studies, we uncovered a novel link between
intracellular changes in the structural morphology of ILC2 mitochondria and the pro-inflammatory capacity
within these cells that results in lung airway inflammation. We found that upon exposure to lung tissue
inflammatory signals, ILC2s increased mitochondrial mass and remodeled their mitochondrial morphology
network from a state of elongated `fusion' to fragmented `fission'. Furthermore, we found that inhibition of
fission during a murine model of papain allergen exposure strongly curtailed ILC2 responses and altered their
metabolic programming, thereby resulting in protection from severe lung inflammation. However, despite these
advances, fundamental gaps in knowledge remain about 1) how remodeling of mitochondrial network
morphology affects ILC2-intrinsic airway inflammation and 2) the identification of the metabolic mechanisms by
which mitochondrial dynamics control ILC2 pro-inflammatory function. Here I propose two Aims consisting of
cutting-edge techniques in cellular metabolism and immunobiology to dissect the role of mitochondrial
morphology dynamics in controlling ILC2 metabolic programming and pathological function during murine and
human allergic airway inflammation.

Public health relevance
PROJECT NARRATIVE Chronic inflammatory diseases of the lung are a major public health and economic concern worldwide and there is an urgent need for deeper understanding of the cellular and biochemical mechanisms that regulate lung inflammation in order to uncover novel targets to improve therapeutic treatments. An immune population called Group 2 innate lymphoid cells (ILC2s) have been shown to be critical in driving lung inflammation through production of type 2 cytokines; however, the molecular mechanisms controlling their functional capacity remain poorly understood. The focus of this R01 proposal is to investigate the role of mitochondrial morphology dynamics in regulating ILC2 function, metabolic programming, and lung inflammation.